Molecular Regulation of GABA(A) Receptor Function in Amygdala

DESCRIPTION (provided by applicant): Comorbid anxiety may predispose addicts to relapse secondary to the biological effects of stress and anxiety on the brain. Furthermore 'hyperexcitability'of the amygdala, as repeatedly seen during stress or fear and substance withdrawal, may contribute to anxiety responses and drug craving. Such increased excitability within the basolateral amygdala (BLA) may be due in part to decreased GABAA activation following stress or substance use. These studies will examine the molecular mechanisms of activity- dependent regulation of GABAA receptors by focusing on fear conditioning and benzodiazepine (BZD) dependence. Both of these manipulations lead to downregulation of GABAA receptors in the BLA. We will compare the molecular mechanisms of GABAA regulation following the stress of fear conditioning with acute, chronic, and withdrawal phases of BZD administration. We hypothesize that: 1) activity-dependent modulation of GABAA within the basolateral amygdala is a common mechanism of both substance dependence and stress response;and 2) GABAergic manipulations that affect BZD response will also affect acquisition and expression of conditioned fear. In this proposal, we will compare the molecular, behavioral, and electrophysiological mechanisms of GABAA regulation following conditioned fear stress with acute, chronic, and withdrawal phases of benzodiazepine administration. We propose that these pharmacological and behavioral events share similar mechanisms involving activity-dependent downregulation of the GABAA complex. A variety of molecular genetic approaches in mice will be used to test this hypothesis including: 1) examination of GABAA complex genes and proteins with in situ hybridization and immunoblotting;2) manipulation of GABAA receptor expression via amygdala-specific deletion of the GABAA alpha1 gene using the Cre/lox system;3) manipulation of post-synaptic GABAA alpha2 gene using Lentiviral-mediated gene silencing;4) manipulation of receptor clustering through silencing of the Gephyrin gene. These studies have direct implications for mechanisms of benzodiazepine dependence, withdrawal, and relapse. Given the role of amygdala GABAergic systems in modulating dopaminergic tone within the nucleus accumbens, amygdala GABAA regulation may have a more general role in addictive disorders. In fact, recent studies have suggested that morphine, alcohol, cocaine and nicotine may also alter GABAA functioning in amygdala, and acutely enhancing GABA levels blocks reinstatement by drug-associated cues or self-administration. This proposal represents a novel approach to understanding shared molecular and cellular mechanisms that may mediate comorbid anxiety and substance abuse disorders. Understanding the mechanisms shared by stress and drug response is critical for understanding pathophysiology and proposing new treatments for these highly comorbid disorders.